Ensuring success in academia for underrepresented faculty to advance biomedical science research

ABSTRACT
Over the past several decades, little has changed in reported experiences of faculty of color at predominately
white institutions (PWIs). Underrepresented minority (URM) scholars at PWIs often contend with numerous
challenges that impact their research success and productivity. There are empirically supported problems with
recruiting and retaining URM faculty in academia and the biomedical workforce. Faculty advancement and faculty
research productivity are closely intertwined with psychological wellness. Faculty that are most well, as defined
by having high levels of social support, mentoring, an enhanced sense of belonging at their institution and a
satisfactory work-life balance are the most successful in academia. There are several programs largely focused
on increasing the pipeline from undergraduate to graduate and post-doctoral scholars, leaving a gap in the
training and mentoring needs of new and mid-career tenure-track faculty that often feel isolated and devalued at
their home institutions. Success for URM faculty is largely driven by knowledge coupled with motivation, self-
efficacy, and tangible support. The overarching goal of the Faculty Accomplished Community that Cultivates
Equity and Success in Science (ACCESS) Program, focused on racial/ethnic URM scholars across the career
trajectory at PWIs, is to provide faculty with tools and resources needed to be successful biomedical scientific
leaders. The Faculty ACCESS Program will center wellness and resiliency to equip multiple marginalized
faculty members to persist towards advancing biomedical research despite systemic, institutional, cultural, and
environmental challenges. To this end, the objectives are 1) To provide programming and mentoring for URM
faculty at PWIs centering wellness and focused on skill building to increase rigorous research
productivity, 2) To provide targeted training in grant-writing to increase NIH grant submissions by URM
faculty, 3) To provide a network of funded URM faculty mentors for trainee participants to enhance social
and tangible support. Expected outcomes of the Faculty ACCESS Program are to facilitate skill development
in rigorous research through wellness to increase publication outputs, increase NIH grant submissions and
resubmissions, and support and prepare faculty for the promotion and tenure processes. Additional outcomes
include increased sense of belonging, self-efficacy, reduced stress, and increased social and professional
networks. The overarching goal is to facilitate success of URM faculty and increase retention in the biomedical
research field which is a stated priority for NIH in the fight to end structural racism.

Public health relevance
NARRATIVE Underrepresented minority (URM) scholars at predominately White institutions (PWIs) often contend with numerous challenges that impact their research success and productivity. There are empirically supported problems with recruiting and retaining URM faculty in academia and the biomedical workforce. The overarching goal of the Faculty Accomplished Community that Cultivates Equity and Success in Science (ACCESS) Program, is to provide URM early and mid-career faculty with tools and resources needed to be successful biomedical scientific leaders by centering wellness and resiliency.